Administrative Core

ABSTRACT
The Administrative Core (Admin Core) supports all aspects of the U54 Partnership for the Advancement of Cancer Research between New Mexico State University and Fred Hutchinson Cancer Center. The Partnership’s cancer research, research education, and outreach activities are made possible through efficient program leadership by Drs. Graciela Unguez and Merranda Marin at NMSU and Drs. Julian Simon and Jaimee Heffner at Fred Hutch. Working jointly, Drs.Unguez, Marin, Heffner and Simon have assembled an Admin Core staff including Program Managers (Ms. Sylvia Saenz Franco at NMSU and Ms. Marilyn Drennan at Fred Hutch) with extensive experience managing the Partnership’s budgets, communications, and logistics. The Admin Core benefits from close ties with institutional leadership on both campuses. Partnership programs are administered collaboratively, and, when feasible, in both locations. The 1,653 mile
separation between the two campuses has necessitated effective long-distance communication since long before the COVID-19 pandemic. Over the Partnership’s 20-year history, the Admin Core has successfully launched and optimized research, education and outreach programs in New Mexico and Washington State through committed effort to long distance coordination, management, and communication. While the pandemic has impacted in-person activities, the Partnership was able to adapt and redeploy resources to advance programmatic goals. The Admin Core has effectively managed allocation of resources, logistical support for in-person and remote program meetings as well as oversight of planning and evaluation of research, education and outreach efforts while consistently maintaining a high level of productivity, effectiveness and impact. The Admin Core’s support of Partnership activities has enabled progress toward meeting the goal of advancing health. Development of the Guiding Principles elaborated in Overall, is a major commitment to meeting that goal.

Public health relevance
Admin Core brings a broad set of expertise and experiences to foster implementation of the Partnership’s Guiding Principles by developing collaborative methods of working towards shared goals. The Core values the perspectives and innovations of each member of the team in a less hierarchical structure than traditional academic units. Even more, it incorporates input from students, university leadership, and community members to provide new insight and innovations that support accomplishing the Aim of the Partnership. Effective functioning of the Admin Core will enable the Partnership to successfully attain the stated Aims.